ITCA NARCH 12 Grant

NARCH Overall Abstract
The overall goal of the Center is to support health research projects that benefit Tribal Members, develop
relationships to enhance tribal governance and partnerships in health research, conduct research that honors
Tribal sovereignty, and promote a cadre of AI/AN researchers in health disparities research. The University of
Arizona and ITCA missions and activities differ in deliberate ways and the AIRCH unites our Tribally governed
501(c) 3 and our research intensive institution to provide a collaborative service to our 21 member Arizona
Tribes, and the Arizona AIAN population. The ITCA and the University of Arizona are fully committed to the
continuing success and impact of AIRCH and are prepared to provide our full institutional resources. Together
we aim to advance the impact of health research by leveraging the university system’s medical center and
health and educational programs to create more effective pathways to benefit our Tribal constituents and to
support Native students and faculty.
The AIRCH XI is comprised of one core (Administration) and four projects to support the following NARCH
objectives:
• To support research opportunities for the enhancement of students, faculty, and researchers
concerned with AI/AN health;
• To build capacity/infrastructure within AI/AN communities to ensure sustainability of biomedical
research and the ability to address pertinent health issues within Tribal communities;
• To disseminate effective individual, community, and population-level interventions to reduce and
encourage the elimination of health disparities; and
• To support research that will reduce health disparities in health and social consequences among
AI/AN.

Public health relevance
NARCH XI - American Indian Research Center for Health Overall Narrative The ITCA American Indian Research for Health (AIRCH) was established in 2000 to reduce health disparities among American Indians and Alaska Natives by engaging tribes in research that is scientifically sound. ITCA works to improve the capacity of tribes in Arizona, including areas related to health. With over 70 staff and 30 projects, ITCA provides on-going technical assistance and over 100 annual trainings to Tribes in program planning and development, research and data collection, and resource development. The AIRCH XII overall goal is to support health research projects that benefit Tribal communities of the ITCA Member Tribes, develop relationships to enhance tribal governance and partnerships in health research, conduct research that honors Tribal Sovereignty, and promote a cadre of AI/AN researchers in health disparities research. Along with the proposal, the AIRCH supports research capacity building and the development of research infrastructure to enhance the biomedical research capabilities of the 21 Member Tribes.